Career Enhancement Program

CAREER ENHANCEMENT PROGRAM RESEARCH PLAN
CEP Director: Simon Powell, MD PhD
CEP Co-Director: Jorge Reis-Filho, MD PhD
Abstract:
The SPORE Career Enhancement Program (CEP) aims to prepare physicians and scientists for independent
careers in translational research in breast cancer. Our goal is that investigators supported through this process
will spend their professional lifetimes conducting translational research in breast cancer and become academic
leaders in the field. Memorial Sloan Kettering Cancer Center (MSKCC) is ideally suited for this task, because of
the scientific and clinical environment at our Manhattan campus and affiliated institutions, and our long tradition
of training physicians and scientists of the highest quality. Our institutional environment includes numerous NIH
training grants, including a K12 grant for translational science training, a T32 grant to train PhDs in translational
research in Oncology, a Certificate Program in Clinical Investigation integrated with the Clinical and Translational
Science Program at Weill Cornell, and a well-established junior faculty mentoring program. We plan to use the
SPORE Career Enhancement funds over the next 5 years to enhance the existing formal mentoring programs.
We will encourage more physician trainees to focus on translational research in breast cancer, in particular to
leverage the emerging knowledge of DNA repair defects and specific patterns of genetic instability in breast
cancers to deliver targeted treatments to individual breast cancer patients. We will strive to attract basic,
translational and population scientists who are interested in devoting their careers to making discoveries that
have a realistic potential to clinical applications. The specific aims of the MSKCC Breast SPORE Career
Enhancement Program are to support the mentoring and research of junior faculty for careers in translational
research in breast cancer, using a dual clinical and laboratory/population science mentorship model, and to
recruit and mentor new junior faculty members to work in breast cancer translational research.

Public health relevance
Narrative: The Career Enhancement Program is designed to support the development of junior faculty by directed funds for pilot research projects and provide mentoring from experienced faculty in clinical and laboratory research. The result of this program will ensure a continuity of research excellence in breast cancer, particularly in how specific DNA repair defects and genetic instability patterns can be leveraged to tailor therapy of breast cancer patients.